A single cell spatial genomics platform for multi-modal characterization of tissue organization

Project Summary/Abstract
Cells are the unit building blocks of tissues and organs, thus, to understand how tissues
function, it is important to understand where different types of cells reside in health and disease.
In this proposal, we propose to develop a novel spatial genomics platform that will enable
multi-modal characterization of tissue structure at the single cell level. This will be
revolutionary for the study of tissue organization in development and pathological changes
in aging and disease. Our tools will enable us to look at RNA, proteins and regulatory elements
in DNA all within the tissue context. We will ensure these novel genomic tools are easy to use
and adopt, which will be especially powerful for pathological settings, where tissue resources
are precious, and adoption of tools is limited by ease of use. The successful completion of
this work will lead to a comprehensive toolset for understanding tissue structure from
the perspective of single cell organization.

Public health relevance
Project Narrative Cells are the unit building blocks of tissues and organs, thus, to understand how tissues function, it is important to understand where different types of cells reside in health and disease. Here, we are developing new technologies that allows us to simultaneously look at who cells are, via the genes they express, and where they reside across whole organs in health and disease.